Mechanisms of Epithelial Cell Behavior and Polarity Establishment

Project Summary
Polarized epithelial cells are the foundational cell type of many organs, and disruptions in polarity and
epithelial organization contribute to diseases of kidney, liver, skin, and intestine. Furthermore, loss of
apical/basal polarity is an early event in many human cancers. Therefore, a deep knowledge of epithelial
morphogenesis is crucial to understanding the development both of normal tissues and of many human
diseases. This proposal builds on our previous NIGMS-funded accomplishments over many years in
understanding the interactions, sorting, and delivery of polarity proteins, as well as deciphering behaviors
of epithelial cells during mammary gland morphogenesis, and of epithelial cell behaviors during human
embryonic stem cell differentiation. The overarching vision of this research program is to enhance our
understanding of epithelial cell polarization and behaviors in tissue morphogenesis.
We will probe the molecular mechanisms of apical intercalation and apical membrane protein sorting, using
mammary epithelial cells in vitro as a model. Intraductal injection of genetically manipulated primary cells
will provide in vivo validation. To gain insight into the extensive re-organization of intercellular junctions
and polarity proteins during apical intercalation, which is an understudied process, we will employ soft
matter physics and computational modeling, advanced live cell imaging, and super-resolution visualization.
Additionally, we will use cells in vitro plus a new mouse model we developed to analyze the role of
actomyosin contractility in both the intercalating cells and the monolayer into which they integrate, to
distinguish competing mechanisms. We will also use our new mouse model to suppress contractility
specifically in myoepithelial cells and fibroblasts of the mammary gland, to determine whether the shaping
of mammary ducts during luminal cell intercalation int the pubertal terminal end buds is driven by physical
constraints on isotropic expansion. Finally, we will investigate the mechanism of apical membrane protein
sorting, based on our unanticipated discovery of a size filter at the Golgi for proteins with small cytoplasmic
domains. Synthetic biology approaches, endogenous tagging, and multiplexed super-resolution
fluorescence imaging will be deployed to identify locations within the Golgi where membrane proteins with
small cytoplasmic domains become segregated from those with large ones. We will also analyze sorting
dynamics of selected apical membrane proteins with intrinsically large cytoplasmic domains and those with
multiple transmembrane domains, to determine how they circumvent this filter. Our research program will
provide valuable insights into fundamental processes underlying cell organization and contribute to
understanding human diseases.

Public health relevance
Narrative Most tissues in the body are composed of polarized epithelial cells, which have a specialized surface that faces the environment, and one that faces inwards. Defects in the formation of these surfaces underlie many human diseases. Our research program aims to reveal the fundamental mechanisms of epithelial cell behavior, using sophisticated microscopy and gene editing techniques, with the goal of discovering at a molecular level how epithelial behavior is controlled and how epithelial cells ensure delivery of proteins to the correct surface.